The RCMI Program in Health Disparities Research at Meharry Medical College

ABSTRACT
Identifying and addressing ethical AI challenges is critical in healthcare domain as AI has achieved
human-level performance in skin cancer classification, diabetic retinopathy detection, chest radiograph
diagnosis, sepsis treatment nowadays, however not too many clinical AI solutions are deployed in hospitals or
actively utilized by physicians. The major problem is that existing clinical AI methods are less trustworthy, non-
explainable, suffer with algorithmic and societal biases, and have security and privacy issues which leads to
misinformation, misdiagnosis, maltreatment, and disparities. Thus, there is a great need to promote awareness
about ethical AI to healthcare professionals (AI algorithm user) and data scientists/computer scientists (AI
algorithm developer) to responsibly develop and deploy AI in healthcare.
We hereby submit an Administrative Supplement in response to the Notice of Special Interest (NOSI)
NOT-MD-23-013. In order to better position Meharry for the challenges posed by the algorithmic biases,
transparency, explainability, and inherently transdisciplinary nature of health disparities, this RCMI administrative
supplement will focus on identifying and addressing ethical considerations in AI/ML technologies in healthcare.
The supplement project will also develop strategies for training the investigators, staff, medical professionals,
and graduate students regarding potential risks, opportunities and challenges for ethical and responsible AI in
healthcare, at the NIMHD-funded RCMI Program in Health Disparities Research at Meharry Medical College.
Therefore, in response to the NOSI (NOT-MD-23-013), this request for the Administrative Supplement will
specifically support collaborations between SACS, RCMI investigators, and medical professionals to identify and
address the ethical considerations of applying AI/ML technologies in healthcare for building trustworthy AI/ML
applications. To promote awareness around responsible usages of AI/ML in healthcare this Administrative
Supplement will specifically focus on two specific aims indicated below.
Aim 1: To identify and address ethical considerations in AI/ML Technologies in healthcare: This aim will
focus on identifying and mitigating bias in the data and AI/ML models developed in the healthcare domain.
Aim 2: Enhance Meharry’s RCMI capacity by providing ethical and responsible AI training to RCMI
investigators, medical professionals, staff, and graduate students: This aim will focus on enhancing
Meharry’s RCMI capacity by providing ethical and responsible AI training to RCMI investigators, medical
professional, staff, and graduate students through a series of virtual tutorial sessions, SACS professional
development training in AI ethics and incorporating the ethical AI concepts in the existing courses.
In summary, the NOSI is aligned with the primary goals of the NIMHD funded RCMI center’s vision “to
focus on the underserved communities health and reduce health disparity through technology and innovation”.
The proposed project will help in identifying and addressing the algorithmic and societal bias in the healthcare
datasets generated and AI/ML models built using those datasets. In addition, the training on trustworthy and
responsible AI will promote awareness among health care professionals, and RCMI investigators for using
ethically sound practices, and develop strategies to reduce health disparity.

Public health relevance
PROJECT NARRATIVE The proposed project will help to identify and address the ethical considerations in AI/ML technologies in healthcare and provide training to RCMI investigators, healthcare professionals and data scientists to define what is an ethically sound responsible AI should comprise of to mitigate the risk of increased health disparities due to bias on race, gender, ethnicity, and demographic characteristics.